CLINICAL, GENETIC, AND CELLULAR CONSEQUENCES OF MUTATIONS IN NA,K-ATPASE ATP1A3

Summary: The neurological importance of the gene for the neuronal alpha3 subunit of the Na/K pump, ATP1A3, is underscored by the severity and range of symptoms produced by its missense mutations: motor, cognitive, and psychological. This project uses an integrated interdisciplinary approach. It includes phenotyping on patients with input on new phenotypes and mechanistic factors. Because new phenotypes are being discovered incrementally, a gene-first search for variants, phenotypes and risk factors in databases linked to clinical data should accelerate that. Variants need to be validated, so there will be laboratory tests of pathogenicity and mechanism, and FDA-approved drugs will be tested for rescue. The purpose is to generate a comprehensive natural history of symptoms and progression needed for future clinical trials, and preclinical data for potential treatments. With ATP1A3 there is an extraordinary range of symptoms including severe infantile manifestations, but the focus here is on the syndromes that manifest in youth and adults: still with a heavy burden, but perhaps also with more immediate hope for treatments that improve the quality of life. We have found that the breadth of symptoms from impaired ATP1A3 activity includes cardiac rhythmogenesis, and in the brain, we have found patients with focal atrophy and others with only reduced metabolism by MRI, where there is hope of restoring function. Moreover, ATP1A3 disease overlaps with many neurologic syndromes, including but not limited to autism, dystonia, parkinsonism, psychiatric disease, and epilepsy. We anticipate that the results of the proposed work will also point to how Na,K-ATPase dysfunction contributes to these more common diseases. Our goal now is towards a treatment by refining our understanding of ATP1A3 mutation phenotype diversity and mechanisms. The aims are as follows: Aim 1) Expand the breadth and reach of ATP1A3 phenotyping, using diagnostic tools to detect ATP1A3-related disease and measure changes over time, necessary for designing treatment trials. Aim 2) Assess ATP1A3 mutations as both causative and risk factors for disabling diseases by using a genotype-first approach to search existing large population and disease- specific sequence databases for ATP1A3 variants and correlate these with phenotypic data from linked electronic health records (EHR) or disease specific phenotype data. Because ATP1A3 mutations are almost entirely missense and heterozygous, the damaged protein must have to be present, leading to Aim 3): Investigate multiple mutations from patients for protein misfolding in rigorously comparable isogenic cell lines. This will test the hypothesis that different symptom clusters have a basis in the cell’s responses to misfolding: adaptation or apoptosis. For mutations that do misfold, test FDA-approved and new misfolding corrector drugs for efficacy. In perspective, both longitudinal phenotyping and knowledge of mutant protein function will be essential for selecting the patient subgroups for either pharmacologic or gene therapy trials.

Public health relevance
Narrative: Genetic mutations in ATP1A3 present with an extraordinarily wide range of symptoms, which is an obstacle to both diagnosis and the development of treatments. We are making two major shifts, one to use an unbiased gene-first approach to the discovery of ATP1A3 clinical consequences, and the other to move toward mechanism-based treatments. A shift towards telemedicine will broaden our reach; partnerships with databases that encompass gene and clinical records will give access to information on patients with or without diagnoses; and laboratory studies will investigate mechanisms of treating mutation damage with a pharmacological approach.